Core-001

DATA MANAGEMENT AND BIOSTATISTICS CORE SUMMARY
This Data Management and Biostatistics Core will serve the needs of each project within this malaria research
center. In this core, we will establish a robust, secure, and comprehensive data management system to serve
all projects and study sites of this center. The data management system will include security features such as
double data entry, date and time stamping of all data records with electronic signatures, audit trails to track
changes made to data and documents, quality-assurance procedures, and a reporting system for summary
information and error reports. All research personnel within this center will be familiarized with the data
collection and processing procedures for standardization of the data format. Data generated from all projects
will be maintained safely on the server in Thailand to provide secure and timely online sharing among
investigators of this center. This core will also serve as the platform for data sharing across ICEMRs and for
uploading individual-level data for public access following NIH guidelines on data sharing. A dedicated team of
biostatisticians will provide biostatistical support at each step of research design, data processing and
statistical analyses, and assist with the writing of manuscripts. This team will also provide training in
biostatistics, software and GIS to participating scientists to help bolster their biostatistical capacity.